Boston University Clinical and Translational Science Institute

The Boston University Clinical and Translational Science Institute (BU CTSI) is an innovative CTSA clinical and
translational research hub and catalyst for national CTSA network science. Boston University and partner,
Boston Medical Center Health System (affiliate with Boston HealthNet, Boston Accountable Care Organization,
VA Boston Health System, Edith Norse Rogers Veterans Hospital and the HealthCore/New England Research
Institutes, Inc.) to comprise the members of the BU CTSI. We serve the largest URG and At Risk patient
populations in New England. Our overarching theme is meant to emphasize our commitment to developing
translational research infrastructure that is appropriate and innovative to meet the standards of the
CTSA Network AND is uniquely designed to meet the needs and overcome the many barriers in
partnering in research with patients at risk for poor health and outcomes. In order to address the health
needs of these communities, the BU CTSI will support workforce development, collaboration across our
stakeholders and integration of translational science across the lifespan of our Special Populations the through
the development of a competent workforce, use of novel informatics, methods and processes that address
disparities of health care. The BU CTSI Goals are:
Aim 1. Discover, demonstrate, deploy and disseminate novel methods in training that will enhance our entire
translational science workforce and create opportunities for advancement.
Aim 2. Develop the most efficient, most representative clinical trials hub possible employing the integrated
resources of all our partners.
Aim 3. Effect meaningful multi-directional relationships among all our community stakeholders that strengthen
collaborative translational research across the lifespan of our special populations and enable novel approaches
to integrating research into health care.
Aim 4. In collaboration with other CTSA hubs, discover, develop and disseminate innovative tools to improve
research on treatments and diagnostics that address national health problems:
The BU CTSI’s vision is to be the strongest possible advocate for, and participant in, translational research that
serves the health needs of our diverse At Risk patient populations by working with our community to create
unique resources that can be integrated with and distributed to the national CTSA network.

Public health relevance
Boston University, The Boston Medical Center Health System, Boston HealtNet, Boston Accountable Care Organization, VA Boston Health System, Edith Norse Rogers Veterans Hospital and the HealthCore/New England Research institutes, Inc comprise the members of the Boston University Clinical and Translational Science Institute (BU CTSI) Hub, supported by a Clinical and Translational Science Award (CTSA) from the National Center for Advancing Translational Science of the NIH. The goals of the BU CTSI, funded since 2008, are: 1. to train a diverse workforce; 2. improve and expedite translational research across the members of the BU CTSI; 3. engage our community in research partnership; 4. develop new methods and resources that improve the science and performance of translational research.